NCANDA Research Project Site: Duke

Initiating excessive alcohol drinking during adolescence is known to disturb typical
neurodevelopmental patterns, increase the risk of developing alcohol use disorder
(AUD), and accelerate involutional processes in adulthood. In response to RFA-AA-21-
007, this application proposes a Research Project Site of the National Consortium
on Alcohol and Neurodevelopment in Adolescence - Adulthood (NCANDA-A) to follow
for the next 5 years a community sample of male and female participants recruited in
three age bands (12-14, 15-17, 18-21years old) when most were no-to-low drinkers and
tracked over the last 8 years across 5 sites (N=831; 93% retention rate). Monitoring has
involved annually acquired multimodal neuroimaging (MRI, DTI, resting state fMRI, task
fMRI), cognitive, clinical, behavioral, and biological data, collected in person or remotely
by computer and our mobile app. These measures will now be complemented with new
advanced neuroimaging and sleep and physical activity tracking. This cohort sequential
design uniquely positions NCANDA-A to quantify transient or enduring alcohol-related
disturbances in specific adolescent and early adult neural system growth trajectories
and functional concomitants.
NCANDA-A proposes four consortium-wide specific aims and two specialty project aims.
In Aim 1, NCANDA-A will investigate the impact of excessive alcohol drinking during
adolescence and emerging adulthood on subsequent developmental trajectories of
cognitive performance, brain structure and function, and psychopathology. Aim 2
analyses will identify neurodevelopment patterns describing the extent to which alcohol’s
effects on brain structure and function resolve or persist during desistance after binge
drinking. Aim 3 will deploy data-driven analysis to identify adolescent biological,
environmental, and behavioral factors (e.g., age of drinking onset) that forecast
excessive drinking during early adulthood. In Aim 4, NCANDA-A will quantify the
impact of a stressful time for many youths during 2020-2021 on life stress and social,
emotional, and economic well-being and their relations with alcohol use patterns. In Aim
5, the SRI and Pittsburgh sites will identify interactions among patterns of alcohol use,
sleep, and cardiac function. In Aim 6, the UCSD, Duke and OHSU sites will determine
the extent to which short-term (i.e., 4 weeks) alcohol use discontinuation results in acute
improvement in cognition, affect, sleep and resting heart rate, and reversal of the
adverse structural and functional brain effects of frequent binge alcohol use. For each
aim, sex differences in development, alcohol use patterns and history, impact of alcohol
use on the brain, and sex-differentiating psychosocial factors will be tested. With the
longitudinal data collected into early adulthood during this renewal, NCANDA-A will
provide novel information to the public on the enduring and transient effects of
adolescent drinking on adult functioning by discovering elements and mechanisms
linking these dynamic processes and identifying modifiable risk factors.

Public health relevance
PROJECT NARRATIVE Heavy alcohol drinking during adolescence is known to disturb brain development and functioning and increase risk of drinking problems in adulthood, but the extent of the lingering effects of youthful drinking on adult functioning remains unclear. The goal of NCANDA-A (Adulthood) is to determine how adolescent alcohol-related disruption of normal brain growth patterns of brain structure, function, and psychiatric health affects abilities in emerging adulthood. Determining which affected processes remain impaired and which escape alcohol's untoward effects will specify how a youthful drinking history influences quality of life in adulthood, information obtained only from longitudinal study as proposed by NCANDA-A.